Building a Diverse Network to Support and Build Pathways for Historically Underrepresented Students in Quantitative-Focused Research Areas Within the All of Us Research Program

Abstract
The overarching objective of this proposal is to increase the quantitative and data management
capabilities of underrepresented minority (URM) undergraduate and graduate students,
postdoctoral fellows, and faculty by providing quantitative research methods training and handson analysis and programming experience with the All of Us Researcher Workbench. Our team has
extensive experience in engaging and training URM researchers to work with the All of Us
Research Program. Our goal is to utilize the Social-Ecological Researcher Engagement
Framework to build upon our existing and proven successful engagement strategies in addition to
implementing novel approaches to engage and train URM students (at various career stages) on
advanced quantitative and programming skills using the All of Us Research Program. This proposal
incorporates four evidence-based approaches for increasing access to high-quality, large-scale
data, promoting quantitative and data management capabilities among URM undergraduate and
graduate students, postdoctoral fellows, and faculty through research training and hands-on
experience with the All of Us Researcher Workbench. These approaches include: (a) collaboration
with institutions across the US that will enable the integration of knowledge, resources, and
training as well as increased awareness to the All of Us Researcher Workbench; (b) training in
highly relevant and deployable quantitative and data science skills for underrepresented students
and postdoctoral fellows; (c) strengthening the quantitative expertise of postdoctoral fellows and
early- to mid-career faculty members of underrepresented backgrounds; and (d) provision of
ongoing technical assistance including statistical guidance, webinars, and individual project
support to collaborative institutions to facilitate accessibility and usability of the All of Us
Researcher Workbench. This program is critical to the development of the quantitatively inclined
public health workforce on multiple levels (e.g., undergraduate students, early career faculty, etc.).
These engagement activity have the potential to influence long term change in the landscape of
public health scholars by making a more diverse and equitable workforce that sphere head
important innovations in the field.